Genetic Dissection of Drosophila Hematopoiesis

? DESCRIPTION (provided by applicant): Molecular mechanisms underlying blood development and disorders are of great interest and importance from the perspective of understanding normal function and leukemia. Drosophila has long served as a genetic model for many developmental processes, but its usefulness as a hematopoietic model has only recently been appreciated. The mechanisms that maintain blood stem cells in Drosophila show remarkable conservation in strategy of development and function with mammalian systems. This study utilizes powerful genetic tools and reagents available for the Drosophila model system to understand how local and global signals affect blood cell development. In particular, we will analyze blood cell differentiation within the fruit fly blood-producing organ to assess how cell cycle, cell differentiation, and organ morphology are influenced during normal development as well as in the presence of stressful environmental stimuli. This proposal consists of three major aims. Aim 1 describes experiments aimed at mapping the organismal connection between defects in CO2 reception and blood cell maturation. In Aim 2 we propose to fully characterize the cell cycle profile of blood progenitors and we will uncover the signaling pathways regulating proteins controlling cell cycle progression. Finally, in Aim 3, we will identify and characterize te effects of tumor growth in epithelial tissue on blood cell development in the mesoderm derived hematopoietic organ. The role of tumor burden on the blood/immune system is of great importance to human cancer and injury, and Drosophila provides an ideal model for understanding the mechanisms in detail. Overall, the research we propose will lead to critical insights into how blood cells are influenced by external and internal stimuli, the mechanisms of which are likely to be conserved in humans. The PI will be involved in mentoring and supervision of the work that will involve the training of 4 postdoctoral fellows and 1 graduate student. Additionally, the laboratory traditionally trains a large number of undergraduates in research. The typical undergraduate spends 2-3 years in the laboratory; postdocs, 5 years and graduate students 5-6 years. The main scientific disciplines our research encompasses include developmental biology and genetics. All graduate and postdoctoral researchers involved are extremely knowledgeable in these two fields, and the more experienced members of the lab will pass along this familiarity to newer members.

Public health relevance
PUBLIC HEALTH RELEVANCE: The genetic basis of blood development and disorders are extremely important to understand in order to make progress on understanding immune challenges and leukemia. The fruit fly, Drosophila, is a model organism in which such studies can be achieved with great predictive power for the human condition. This proposal seeks to understand the local and systemic molecular mechanisms underlying control of blood cell proliferation and differentiation and how environmental stimuli (including CO2 reception and tumor burden) influence this regulation.